Supplement Request: The Role of Anillins in Gradient Tracking

Project Summary - No updates from original submission
GPCR signaling drives cell polarization in the yeast pheromone response. In response to
pheromone, cells polarize their cytoskeleton and make a mating projection to fuse with a mating
partner. At the base of these mating projections are septin structures, serving to anchor signaling
proteins and promote membrane curvature. Septins are also important for mitosis where they play a
key role in cytokinesis. Anillins are conserved signaling proteins responsible for coordinating the
septin cytoskeleton with microtubules, actin, and Rho signaling during cytokinesis. In this proposal,
we seek to characterize the role of the anillins Boi1 and BOi2 in regulating septins during the
pheromone response. We hypothesize that this contributes to polarized growth and that the anillins
signal through regulation of the PP1 phosphatase. In Aim 1, we will examine what signaling events lie
upstream of anillin function during the pheromone response. We will use live cell microscopy in
microfluidic devices, computational image analysis and yeast genetics to test the role of different
anillin domains in controlling the localization of the anillins during the pheromone response. In Aim 2,
we will examine the downstream effects of anillin function in the pheromone response. Using the
same technical approaches as in Aim 1, we will test the effect of anillins perturbation (mutations and
deletions) on downstream polarity signaling, septin dynamics, gradient tracking, and mating. We
anticipate that we will discover a non-mitotic role for anillins in the regulation of the septin
cytoskeleton. The signaling networks we are studying are conserved from yeast to humans, where
anillins are expressed in neurons and overexpressed in cancer. Thus, these studies will enhance our
understanding of anillin and septin roles in human health.

Public health relevance
Project Narrative - No updates from original submission Anillins are proteins involved in shape changes necessary for cell division, but we are studying the ability of anillins to control cell shape outside of cell division. The ability of cells to change their shape to accomplish different tasks, such as cell movement in cancer or growth into specific shapes necessary for neuron function, is broadly important to human health.